Hierarchical cortical circuitry supporting 3D visual perception and oculomotor function

PROJECT SUMMARY/ABSTRACT
Primates are uniquely capable of interpreting external stimuli and responding in behaviorally advantageous
ways. A key neuronal process supporting these abilities is the sophisticated level to which their visual systems
construct three-dimensional (3D) representations of the world from two-dimensional (2D) retinal images. Indeed,
3D spatial processing was a driving factor in the evolution of the primate brain and human analytical abilities.
Today, deficits in 3D processing help define certain neurodevelopmental disorders. Our overarching hypothesis
is that 3D visual perception, oculomotor processing, and the formation of sensorimotor associations that facilitate
strategic behaviors are collectively supported by a little-studied V3A → caudal intraparietal (CIP) hierarchy that
bridges occipital and parietal cortex. However, there is a critical gap in the understanding of these areas’ causal
roles in perception and it is unknown if shared circuitry within this hierarchy jointly supports visual and oculomotor
functions. Here we propose new experiments with macaque monkeys that combine behavioral, high-density
electrophysiological, and causal manipulation techniques to fill these gaps. In Aim 1, we will assess the causal
contributions of V3A and CIP to 3D perception. The experiments will use electrical microstimulation (EM) to
manipulate neuronal activity in each area while the monkeys perform an eight-alternative forced-choice (8AFC)
surface orientation (tilt) discrimination task. We hypothesize that weak currents applied to clusters of V3A/CIP
neurons with similar visual selectivity will systematically bias the 3D orientations reported by the monkeys. The
predictions for which neuronal/stimulus factors will determine the direction and magnitude of the induced biases
are hypothesis driven and highly site specific. A comprehensive linear regression model will be used to test our
hypotheses that biases will: (i) have distinct relationships with the stimulus tilt (relative to the preferred tilt at the
EM site) and slant, (ii) be larger at EM sites with 3D object selectivity compared to lower-level visual feature
selectivity, and (iii) be larger when CIP is stimulated than V3A. In Aim 2, we will test if the areas carry presaccadic
activity and if training shapes sensorimotor associations between the neurons’ visual and saccadic properties.
Specifically, in Aim 2A we will use overlap and memory-guided saccade tasks to test for presaccadic activity
and evaluate two alternative hypotheses regarding sensorimotor associations in monkeys naïve to the 8AFC tilt
discrimination task. Namely, whether an alignment of surface tilt and saccade direction preferences in V3A/CIP
naturally occurs in the circuit or is flexibly learned and dependent on sensorimotor training. In Aim 2B, we will
assess the mechanisms (visual and/or saccadic) supporting sensorimotor associative learning and their temporal
dynamics by tracking the relationship between visual selectivity and presaccadic activity as a function of training
(duration & performance level) on the 8AFC discrimination task. By testing the causal roles of these two
interconnected cortical areas in 3D perception and if shared circuitry jointly supports visual/oculomotor functions,
this work will advance the understanding of processes that enable primates to uniquely thrive in a 3D world.

Public health relevance
PROJECT NARRATIVE This research will contribute fundamental knowledge about how primates perceive and interact with the three- dimensional (3D) world. In the short term, it will reveal how ecologically relevant representations of the world are created from ambiguous sensory signals and in the long term provide insights for treating neurological disorders, brain injury, and cognitive dysfunction. Because 3D vision is a major component of virtual and augmented reality, the public health relevance of this work extends to industry which faces growing demands to develop devices that are safe, persuasive, inclusive, and have therapeutic value.